Role of lymphocytes and newly discovered cochlear lymphatics in the foreign body response following cochlear implantation

Project Summary
Cochlear implants (CIs), provides auditory rehabilitation for patients with severe to profound sensorineural
hearing loss and can now benefit patients with significant residual low frequency hearing. Implant function and
residual hearing can be negatively affected by post-CI inflammatory foreign body response (FBR). While
significant body of work has been devoted to probe the role of infiltrating macrophages, the role of lymphocytes
has not been thoroughly scrutinized. Moreover, antigen presenting cells (APC e.g., macrophages) are known to
mobilize from the end organ to lymph nodes via lymphatic vascular network to present antigen to lymphocytes,
activate and recruit lymphocytes. A cochlear lymphatic network has never been described. Using a lymphatic
reporter mouse and highly sensitive and specific tracer molecule for lymphatic vessels, we have discovered a
rich lymphatic network in cochlea. Besides, in a murine model of CI, we have observed lymphocyte infiltration
and activation reinforcing findings in human studies. Given the potential importance of lymphatic anatomy and
lymphocytes in the cochlea in understanding and combatting the FBR in CIs, this study proposes to investigate
the role lymphatics and lymphocytes in the FBR post-CI. The long-term goal of this project is to investigate
fundamental basis of cochlear immune responses to damage. The objective of this study is to determine the role
of lymphatics and lymphocytes in the inflammatory FBR post-CI. The central hypothesis is, following cochlear
implantation (1) macrophages (APCs) travel through the lymphatic network to present antigens to the
lymphocytes and that (2) lymphocytes are necessary for chronic inflammatory FBR post-CI.
Undertaking the following two aims, we will test our hypotheses:
1) To characterize the pathophysiological changes in cochlear lymphatic drainage post-CI, we will first establish
the pattern of lymphatic drainage of cochlea to lymph node basin by injecting lymphatic tracers into cochlea of
lymphatic reporter mice followed by imaging of cochlea and head neck region. To investigate whether cochlear
implantation results in increased mobilization of APCs to cochlear lymphatic vessels, we will perform CI surgery
in lymphatic reporter mice, determine the density of APCs within cochlear lymphatics, and compare with
appropriate controls.
2) To determine whether lymphocytes are necessary for the inflammation and foreign body response, cochlear
implantation will be performed in lymphocyte deficient mice, FBR will be quantified and compared with
appropriate controls.
When successful, these aims will enhance our understanding of the immune response following cochlear
implantation. Beyond cochlear implantation, these innovations will shift the current paradigm of cochlear immune
response and likely lead to novel therapeutic interventions for a myriad of inner ear pathologic processes.

Public health relevance
Project narrative A foreign body response (FBR) following cochlear implantation (CI) has been associated with increasing electrical impedance, loss of residual hearing, and limitations in the functionality of cochlear implant. The proposed research aims at improving our understanding of role of lymphocytes, a type of immune cells, and recently discovered inner ear lymphatic vessels, that acts as conduit for immune cells, to the FBR following CI. This has profound public health significance as CI provides auditory rehabilitation and improve the quality of life of people with sensorineural dysfunction, the most common sensory abnormality in adults.